CYCLOSPORINE MICROEMULSION IN PEDIATRIC TRANSPLANT RECIPIENTS

To determine the absorption of the new microemulsion of cyclosporine in pediatric patients, determine the variability of the drug based on age, size, sex and other drugs, to correlate the trough level, maximal concentration, area under the curve in order to establish the optimal pattern to monitor drug administration, and to determine if AUC can be accurately measured with a minimum number of blood cyclosporine levels.